The Stanford-SLAC CryoEM Center (S2C2)

Project Summary This is a supplement request for the purchase of Vitrojet which is a new generation of jet freezing device. It has been shown that it will provide a more uniform and thin embedding ice for preserving single particle samples. In addition, this device has a potential merit of minimizing the specimen deterioration at the water-air interface because no blotting is applied to thin the sample. This instrument will be accessible to all users of our Center.

Public health relevance
Project Narrative The Stanford-SLAC Cryo-EM Center has the dual mission of providing the community with cryo- electron microscopes for data collection and cross-training personnel from any research institutions to become independent cryo-EM investigators. In this supplement proposal, we would like to request funding to acquire a new freezing apparatus accessible to the general user community in our Center.